Imaging Dynamics in Anxiogenic Serotonin Circuitry

Contact PD/PI: Wright, Emily Clarissa
PROJECT SUMMARY
Anxiety disorders are the most commonly diagnosed mental illnesses; national prevalence data indicate that
about 20% of adults in the US will be diagnosed. Selective serotonin reuptake inhibitors (SSRIs) are one of the
most widely used treatments, yet 40% of patients do not respond. Despite decades of targeting serotonin, a
consensus on serotonin function and release dynamics is lacking. Consequently, how SSRI administration
modulates fine temporal dynamics of serotonin in relation to anxiety is largely unknown. Pharmacological
approaches, microdialysis, and chemogenetic manipulations have produced key insights, but none provide
millisecond resolution for serotonin release and correlates of specific reactions and behaviors until recently,
due to the development of two sensitive genetically encoded serotonin sensors (sLight and iSeroSnFR). I will
these sensors combined with fiber-photometry to optically measure behaviorally driven serotonin release in an
anxiogenic serotonin circuit with high temporal and spatial resolution.
The series of experiments outlined in this proposal are significant because they will: Aim 1) rigorously
demonstrate the in vivo utility of serotonin sensors in dissecting anxiety circuit, providing end users important
protocols and guidelines for fast technological implementation; Aim2) map dynamics of serotonin release in
anxiogenic circuits to anxiety behavior, and discover how activity in this circuit is impacted in anxious animals
and determine the mechanistic impacts of acute vs. chronic SSRI administration on anxiogenic serotonin
signaling; Aim 3) determine how testosterone impacts the efficacy of SSRI treatment.
Project Summary/Abstract Page 6

Public health relevance
Contact PD/PI: Wright, Emily Clarissa PROJECT NARRATIVE In this proposal, I aim to apply these two sensors combined with fiber-photometry to optically measure behaviorally driven serotonin release in an anxiogenic serotonin circuit with high temporal and spatial resolution. This information will be made publicly available and become fundamental data to guide future research with the sLight and iSeroSnFr biosensors. I will use these sensors to answer previously unapproachable questions about functional role of serotonin in an anxiogenic circuit and mechanistically address gaps in SSRI efficacy. Project Narrative Page 7